Determining the role of the long non-coding RNA HOTTIP in regulation of the HOXA gene cluster

Project Summary/Abstract
Most transcription occurring in the human genome produces RNAs that do not encode proteins,
and disruption of these non-coding RNAs (ncRNAs) is associated with multiple cancers. It is
necessary to fully understand the role ncRNAs play in disease so that treatments and medicines
can be developed. This project studies a particular ncRNA called HOTTIP which controls the
expression of HOXA genes during the development of limbs. HOTTIP recruits the histone
methyltransferase MLL1 to HOXA genes, however the mechanism of recruitment is unclear. By
understanding how HOTTIP functions as a regulatory molecule, we can improve our knowledge
of ncRNAs generally and identify ways to target ncRNAs therapeutically. This project involves
creating a new technology through molecular engineering to determine the role of HOTTIP
rapidly and confidently in human cells. It will be possible to uncover the exact way HOTTIP
interacts with the MLL1 complex, and the degree the RNA molecule of HOTTIP itself is central
to regulation of HOXA genes. This technology can then be used to study the thousands of other
ncRNAs found in the human genome.

Public health relevance
Project Narrative The human genome encodes every protein in the body, and the effects of abhorrent gene expression lead to a plethora of diseases such as cancer and developmental defects. Therefore, it is essential for scientists to fully understand how the genome is regulated and have tools to study regulation in the genome. This project uses the long non-coding RNA HOTTIP as a model to investigate how genes are regulated at the HOXA gene cluster.